Rapid Acute Leukemia Genomic Profiling with CRISPR enrichment and Real-time long-read sequencing

PROJECT SUMMARY/ABSTRACT
Background: Acute myeloid leukemia (AML) continues to have high mortality rates despite a plethora of
available treatments. Variable prognosis, treatment response and survival are largely based on cytogenetic and
molecular aberrations that characterize AML subtypes. Fast and cost-effective methods of detecting AML fusions
and mutations could improve clinical outcomes for patients, as standard next generation sequencing (NGS)
methods are limited by several technical and bioinformatic issues.
Hypothesis: We have developed a CRISPR-based single molecule long-read sequencing assay (CSRL) to
quickly detect clinically relevant mutated genes in AML. This new methodology, combined with new bioinformatic
approaches, allows for same day results of sequencing data. We hypothesize that such technology can be
improved to detect both mutation and translocations common in AML, and that this rapid turn-around-time will
positively impact patient care by allowing swift risk stratification and treatment selection.
Proposal: In this study, we expand the CSRL assay to include more relevant mutations and translocations.
Specifically, we will ask and answer 1) Will the CSRL assay identify all the mutations and fusion in the target
genes seen by NGS and cytogenetics? 2) Do the single molecule reads provide a more accurate assessment of
tumor burden? 3) Do CSRL data allow for determination of phasing of mutations and provide additional
prognostic or predictive significance? 4) Is same-day sample collection and result reporting clinically feasible for
the AML CSRL assay and how will obtaining same-day CSRL results impact clinical decision making? 5) What
improvements can be expected upon the current turnaround time, costs, and assay performance in comparison
to standard NGS? To answer questions 4 and 5, we will conduct a pilot clinical trial to test feasibility of clinical
implementation. Research Design/Specific Aims: Specific aims: SA1) To expand our CSRL sequencing
assay and optimize current bioinformatics workflow to allow for same-day diagnosis (~8 hours). This
development will use a multiplexed CRISPR enrichment library of long nucleic acid molecules on a low cost
Nanopore device. SA2) Validate sensitivity and specificity of the assay developed in SA1 and evaluate
prognostic impact of phasing data provided by long reads and single molecule quantification for more
accurate tumor burden assessment. We will test the proposed method on a set of clinically annotated leukemia
samples with existing molecular data obtained with standard NGS and cytogenetics. SA3) To establish clinical
utility of CSRL sequencing with same-day leukemia molecular diagnosis. The purpose of this specific aim
is to demonstrate the clinical impact of our same day ultrarapid molecular profiling assay through a pilot study
on 10-12 patients at our cancer center. We will test real world feasibility of implementing these methods on
samples from the clinic, ease of same day testing and reporting, and study the impact same day results could
potentially have on how oncologists treat their acute leukemia patients.

Public health relevance
PROJECT NARRATIVE Acute leukemia (AL), a cancer of the blood, has variable prognosis, treatment response and survival depending on the specific subtype, which is characterized by genetic alterations, but current standard-of-care testing takes 2 to 4 weeks to fully characterize and subtype an AL and requires highly skilled staff as well as multiple expensive instruments and reagents. We have developed an ultrarapid (same day sample to reporting) assay using real-time long read DNA sequencing to achieve faster and more cost-effective detection of AL mutations/fusions and build upon our current computational methods and software tools to support reproducible data analysis and enable interactive interpretations for biomedical users. We propose to first expand this assay to add additional targets for AL prognostication and therapy guidance, then to validate an optimized CSRL assay and bioinformatics workflow, and finally to run a pilot trial to show feasibility of clinical implementation.